Data Management and Analysis Core

CORE SUMMARY – DATA MANAGEMENT AND ANALYSIS CORE
Real-life exposures to hazardous substances from Superfund sites occur as mixtures of many contaminants. To
improve and protect human health from exposure to hazardous substances, Superfund Research Centers (SRCs)
must integrate biomedical research with environmental science and engineering. The integration of data from
the diverse scientific disciplines in SRCs is critical if we are to fully understand the link between exposures and
disease and prevent adverse health outcomes. Therefore, the data generated by the SRC represents an important
research product that requires best practices for quality assurance, dissemination, and interoperability. The
primary objective of the Data Management and Analysis Core is to discover, implement, and promulgate best
practices for fostering and enabling the interoperability of data between biomedical research projects and
environmental science and engineering projects to accomplish the goals of the overall Center. We will coordinate
the development and refinement of an integrated data management plan for the entire Center. We will work
closely with project & core leaders to identify data sharing platforms and to prioritize datasets for sharing across
the program. We will establish data sharing guidelines and timelines. We will also continue to provide expert
statistics for experimental design and multivariate data analyses. We will continue to develop and maintain
software that provides an integrated data workflow for raw experimental data, important sample metadata, and
downstream analysis pipelines. We will continue to model dose-response curves and biological response data.
We will expand the SRP Analytics Portal with new data templates and implement data visualizations to facilitate
data sharing and interpretation. The Portal also supports Findability, Accessibility, Interoperability and
Reusability compliance and facilitate public data sharing with the scientific community. We will apply novel
machine learning approaches to all processed data streams to link polycyclic aromatic hydrocarbon exposure to
outcome, and to ultimately predict the effects of chemical mixtures on biological systems. We will work closely
with project and core leaders to ensure high data quality throughout the lifecycle of data generation. We will
review data, document quality control procedures that account for experimental, technical, or systematic
problems, and resolve problems at each step of the data life cycle. We will integrate results across all research
projects and cores and train the next generation of toxicologists to analyze their own data.

Public health relevance
CORE NARRATIVE – DATA MANAGEMENT AND ANALYSIS CORE The Data Management and Analysis Core (DMAC) develops an integrated data management plan for the entire Superfund Research Center. The DMAC facilitates data sharing and interoperability through custom software solutions and advanced data science to enable data integration from biomedical research projects and environmental science and engineering projects. The DMAC implements best practices for statistically robust experimental design, data pipelines, data integration, and data management to characterize the chemical identity and toxicities of polycyclic aromatic hydrocarbons commonly found at Superfund Sites, and to elucidate the links between exposures and disease.